KanSurvive: Testing a model for improving cancer survivorship care in rural practice

ABSTRACT
Cancer survivors in the acute and extended phases of care would benefit from improvements in the quality and
coordination of primary and cancer care they receive. Cancer researchers have left the management of rural
cancer survivors largely unstudied. While evidence-based practice guidelines exist, implementation in rural
primary care practices has fallen short. Studies have yet to fully identify the barriers preventing successful
implementation of guidelines in these settings. Opportunities exist to improve the understanding of both the
reasons why cancer survivorship care is sub optimal in rural primary care as well as to test mechanisms for
helping practices implement systems that assure all cancer survivors can be identified and are receiving
guideline concordant care. This study sets out to evaluate current practices in managing rural cancer survivors
and test a KanSurvive Project ECHO intervention to transform practices for delivery of evidence-based
survivorship care. The primary aims are to 1) describe gaps in care, infrastructure needs and processes of
care for acute and chronic cancer survivorship in rural primary care clinics focusing on rural breast, colorectal,
lung, and prostate cancer survivors while finalizing the KanSurvive Project ECHO intervention; 2) evaluate the
effectiveness of practice facilitation integrated with telementoring program for enhancing adoption of evidence-
based practice guidelines for breast, colorectal, lung, and prostate survivors; and 3) describe key facilitators
and barriers to implementation of KanSurvive Project ECHO and evidence of related EHR documentation
change in these practices. This novel project will provide a model for use of implementation science and the
development of a “community of practices” working together to improve rural cancer survivorship care from
diagnosis to the end-of-life.

Public health relevance
Project Narrative This will be an observation study to evaluate the reasons practices providing care to rural cancer survivors (time of diagnosis through the life-span) do/do not implement evidence-based practice (EBP) cancer survivor ship care and subsequently to test KanSurvive Project ECHO, an implementation and practice transformation intervention to increase EBP guidelines in rural cancer survivors.